ECM Proteomics in lung fibrosis

PROJECT SUMMARY/ABSTRACT
Idiopathic pulmonary fibrosis (IPF) is a progressive and fatal chronic lung disease, affecting over 5 million people
worldwide. To date, there are no therapies that effectively stop progression or reverse the disease. IPF is
characterized by altered cellular composition and dysfunction of epithelial-mesenchymal interaction in the
peripheral lung, leading to excessive accumulation of extracellular matrix (ECM) and progressive scarring. The
IPF lung is characterized by a heterogeneous distribution of normal or mildly affected regions, alternating with
regions of significant fibrosis containing septal thickening, honeycombing, aberrant epithelial reprogramming,
and fibroblastic foci. Since homeostasis and regeneration of the human lung after injury is controlled by delicate
interplay between the ECM and multiple resident cell populations, it is imperative to define the sequential
contributions of enhanced ECM secretion and crosslinking on cellular functions. Hence, the definition of the
sequential hierarchy of enhanced ECM composition or stiffness obtained by crosslinking enzyme activity on
resident lung cell function will enable the identification of precise therapeutic angles for IPF. The overarching
goal of this application is to define the composition and crosslinking pattern of the fibrotic ECM, to
assess the contribution of fibroblasts to the fibrotic ECM, to mechanistically interrogate the contribution
of a prototypic crosslinking enzyme, transglutaminase (TGM) 2, to the above, and to assess its reciprocal
effect on alveolar epithelial cell function. We hypothesize that IPF ECM exhibits specific changes and cues,
produced by resident fibroblasts and generated by TGM2-dependent crosslinks, which in turn alter lung epithelial
cell function and reprogramming. To pursue this hypothesis, we propose a cascade of specific aims: In Aim1,
we will utilize a novel proteomics approach in order to define, quantify, and validate, in the greatest possible
detail and accuracy, changes in the composition and architecture of the ECM in lung fibrosis by quantifying its
composition and crosslinking patterns. In Aim 2, we propose to identify the ECM secreted by control and IPF
primary fibroblasts and determine the effect of fibroblast-derived TGM2 on ECM composition and crosslinking.
In Aim 3, we will investigate whether and how fibroblast-derived TGM2 affects development of lung fibrosis and
ATII cell reprogramming. This proposal is based on the new concept that resident lung cell fate is reciprocally
determined by the (fibrotic) ECM. The proposed project will provide unprecedented detail and novel insights into
ECM composition and crosslinking patterns in the normal and fibrotic human lung. We will generate novel
knowledge on ECM-cell interaction with respect to resident lung cell function and tissue regeneration in IPF. The
project will explore a major under-investigated area in lung pathologies and provide substantial groundwork for
the development of novel therapies for IPF, which likely will extend to other chronic lung diseases driven by
changes in ECM composition, such as asthma, chronic lung allograft dysfunction, or COPD.

Public health relevance
PROJECT NARRATIVE Idiopathic pulmonary fibrosis (IPF) is a chronic and fatal interstitial lung disease affecting over 5 million people worldwide, and is characterized by progressive destruction of functional lung tissue with increased extracellular matrix (ECM) deposition and architecture. To date, there are no therapies that stop the progression or reverse the disease. Here, we aim to accurately define the three-dimensional composition and structure of the fibrotic ECM, and its cues for and interaction with lung resident cells, with the aim to identify novel regenerative approaches for the treatment of IPF.